Developing Teixobactin for Respiratory Infections

ABSTRACT: The major goal of this proposal is to investigate the potential for teixobactin, our newly discovered
antibiotic, to treat respiratory infections. As reported in 2019 by the CDC, pneumonia caused by drug resistant
Streptococcus pneumoniae, as well as methicillin-resistant Staphylococcus aureus (MRSA), are considered
serious threats. In addition, respiratory bacterial co-infections with Covid-19 have recently been recognized as a
significant problem. Haemophilus influenzae and Moraxella catarrhalis are two other respiratory pathogens
particularly problematic in patients with chronic obstructive pulmonary disease and are common causes of
community-acquired bacterial pneumonia (CABP).
The most remarkable, and unexpected property of teixobactin is the lack of any detectable resistance to
this compound. Teixobactin hits two related targets—lipid II, precursor of peptidoglycan and lipid III, precursor of
wall teichoic acid. These highly conserved targets are not mutable—they are not proteins and are not directly
coded by DNA. Since our discovery of teixobactin, we and others have failed to generate resistant mutants in
any species including S. aureus, Mycobacterium tuberculosis or Bacillus anthracis. Teixobactin is highly
efficacious in animal models of thigh, lung and blood infections. Animal infection models predict that the human
dose of teixobactin for acute skin and skin structure infections (ABSSSI) will be very low (≤1 mg/kg/day), which
is advantageous, as a low dose may minimize side effects and reduce manufacturing costs.
Teixobactin is in preclinical development as an intravenous (IV) drug for treating skin infections caused
by pathogens such as MRSA. A pre-Investigational New Drug (IND) meeting with FDA was held in December
2018 whereby the FDA generally agreed with our development plan. An IND submission for ABSSSI is planned
for 2022.
In this project, Aim 1 will produce enough teixobactin for all the proposed studies. Aim 2 will conduct
efficacy and PK/PD studies in animal models of pneumonia. Aim 3 will test in vitro susceptibility, bactericidal
activity, post antibiotic effect (PAE) and resistance in recent clinical isolates from respiratory infections. Aim 4
will prepare and submit an IND application for intravenous treatment of a respiratory infection. Aim 5 will explore
alternative routes of TXB administration (inhalation and intramuscular delivery), which would be particularly
useful for outpatient treatment of respiratory and other infections. With successful completion of these projects,
we will have demonstrated the promise of teixobactin for treating drug resistant respiratory infections and
explored more convenient routes of TXB administration.

Public health relevance
NARRATIVE Pneumonia is one of the most common infectious diseases and remains a significant cause of morbidity and mortality due to resistance to current antibiotics (CDC, 2019). The focus of this project is to advance our newly discovered antibiotic teixobactin to treat drug resistant pneumonia.